RFA-CK20-004: Prevention Epicenters Program: Protecting Patients from Infections, Antibiotic Resistance andOther Adverse Events

We have been a member of the Prevention Epicenters (Cycle II, RFA-CK-18-001) since 2015. Our core
investigative group has over 430 publications in the area of healthcare-associated infections and antibiotic
resistance which have been cited over 12,000 times. The leaders of our core projects have had more than 27
grants and contracts as principal investigators and have over 350 publications in the scientific expertise areas
in the RFA. We have collaborated with the current Epicenter II sites on 53 publications since 2015 and have
collaborated with current Epicenter I sites on 35 publications. One of our group’s greatest strengths is our
ability to leverage our experience and expertise to complete collaborative projects among the existing
Epicenters and other healthcare institutions. We propose core and collaborative projects that are innovative,
feasible and responsive to CDC priority areas.
Our core proposals are:
1. State-wide prevalence of multi-drug resistant Acinetobacter baumannii in ventilated patients in acute and
long-term facilities.
2. Evaluation of use and usability of surveillance for hospital-onset bacteremia and fungemia in acute care
facilities
3. Decreasing Transmission of Multi-drug Resistant Organisms in Chronic Ventilator Units in Nursing Homes
4. Assessing feasibility of a targeted approach to contact precautions for MRSA in the acute care setting
5. Improving clinician microbiology test interpretation and use in all healthcare settings
Our collaborative project proposals are:
1. Risk factors associated with transmission of Candida auris in the acute care setting (Large Project)
2. Diagnostic Stewardship for Ventilator Associated Pneumonia: A cluster-randomized crossover trial of a
hybrid order-review and laboratory reporting intervention in acute care facilities (Medium project)
Through these projects and the development of other collaborative projects, we look forward to contributing to
the Prevention Epicenters Program: Protecting Patients from Infections, Antibiotic Resistance and Other
Adverse Events.

Public health relevance
Healthcare-associated infections (HAI) and antibiotic-resistance (AR) increase patient morbidity and mortality. The proposed work will lead to new strategies for preventing HAI, AR and other adverse events in all types of healthcare facilities in the United States.